Evaluating the Implementation of High Intensity Home-Based Rehabilitation Following Stroke

Project Summary
Stroke is a highly prevalent condition that contributes to significant deficits in functional mobility, particularly in
older adults. To address these deficits, post-acute rehabilitation is an evidence-based component of care.
However, facility-based rehabilitation (i.e., in a skilled nursing or inpatient rehabilitation facility) is costly. If
stroke patients can achieve the same outcomes in a high-intensity home-based rehabilitation (HIHR) approach
as in these facilities, the relative value (outcomes/costs) would be greater. The effectiveness of such an
approach has not been studied. Further, the implementation of a HIHR care model has not been examined in
the US health system. The objectives of the proposed research are to identify barriers to initial HIHR efforts
implementation in one health system and to understand its clinical effectiveness to inform subsequent
improvement of the care model. A hybrid type 2 study design with a triangulated mixed methods approach will
be used over two cycles of a learning health system research framework. Specific aims are to (1) explore
barriers affecting the initial implementation of HIHR for stroke patients, (2) compare the effectiveness of HIHR
to facility-based rehabilitation on improving patients' function, and (3) implement a refined HIHR model and re-
examine its implementation and effectiveness. We hypothesize that clinical workflow challenges and
patient/caregiver preferences will affect the outcomes with initial implementation and that patients' function at
HIHR discharge will be at least equivalent to patients' function at facility discharge. We also hypothesize that
improvements in implementation and effectiveness outcomes will be achieved by refining the HIHR model after
learning from the evaluation of the initial model. These aims align well with the candidate's goal to become an
independent learning health system researcher, with an emphasis on studying rehabilitation practice in health
systems. Training aims are to (1) develop expertise in mixed methods research and its application to care
delivery, (2) gain expertise in assessing implementation success of a health system innovation, (3) develop
expertise in comparative effectiveness research using observational data, and (4) develop skills to engage with
health system leaders and lead a learning health system research lab. These training aims will be
accomplished via one-on-one mentorship with content experts and combination of local and national
coursework. All scientific and training aims will be accomplished in an environment that includes a large
integrated academic health system and a partner institution for didactic instruction. The expected outcome of
this work is a description of the implementation and effectiveness outcomes for HIHR. This is an innovative
approach for post-acute rehabilitation following stroke that does not currently exist in the US health system, but
which may substantially affect the value of care that aims to improve patients' functional independence
following stroke.

Public health relevance
Project Narrative A stroke causes significant disruption in the ability of individuals to participate in functional activities that are associated with every-day living. Clinical guidelines recommend rehabilitation to address functional deficits, but the cost of that rehabilitation in skilled nursing and inpatient rehabilitation facilities is becoming increasingly unsustainable. The goal of this project is to examine whether a high intensity home-based rehabilitation approach can be successfully implemented and contribute to functional outcomes similar to those that are achieved in those costly facilities.